GAMMAGARD FOR ENTEROVIRAL INFECTIONS--INTRAVENOUS IMMUNOGLOBULIN

Enteroviral infections of newborns, for which no specific therapy is available, can produce significant morbidity. This study will analyze whether gamma globulin infusions can ameliorate the course of these infections.